CARD - Senescent Phenotypes of Isogenic iPSC-Derived Alzheimer's Disease and Related Dementia Models at Cellular Resolution

Toward our aim of determining which genetic risk variants of ADRD sensitive cells to senescence, we have created a pilot experimental plan for the establishment and optimization of iPSC-derived neuronal senescence in the KOLF2.1j parental line. Using genotoxic stress induced by doxorubicin treatment, we are finding the optimal dose of senescence to induce a stable senescent phenotype in culture. We will develop multi-omic (proteomic and transcriptomic) signatures of senescence in neurons, and then systematically test the propensity of other ADRD risk variant-engineered cells to become senescent based on these signatures. The proposed work would systematically test whether genetic variants associated with ADRD are mechanistically linked to cellular senescence as a potential driver of aging.